Exploring the Effects of Cannabinoids on Alcohol Consumption and the Microbiota-Gut-Brain Axis

Summary
Increasingly liberal cannabis policies in the U.S. have been associated with both “replacement”, whereby
cannabis is substituted for alcohol, thus decreasing alcohol use, and “enhancement”, whereby cannabis use
increases alcohol use. These conflicting patterns may be partially explained by the fact that the potency of
delta-9-tetrahydrocannabinol (THC; the main psychoactive cannabinoid in cannabis) in cannabis in the U.S.
varies widely, with legal-market cannabis containing increasingly higher THC potencies. When combined with
alcohol, cannabis may confer either synergistic or mitigating effects on craving, impulsivity, cognitive
impairment and subsequent drinking, likely depending on several factors, including cannabinoid dose and
content. The limited literature in this area has generated conflicting findings; some studies have shown that
THC increases alcohol intake and has synergistic effects on the subjective effects of alcohol, and others have
shown that THC decreases alcohol intake or has no effects on these outcomes. Emerging work also suggests
that alcohol and cannabis exert opposing effects on the digestive, immune, and central nervous systems,
collectively known as the microbiota-gut-brain-axis (MGBA). Alcohol is linked to immune dysfunction and
disturbances in gut microbial species (microbiota), and these MGBA disruptions have been associated with
neurobehavioral AUD symptoms (e.g., craving, impaired control). Conversely, preclinical data suggest that
cannabinoids may confer beneficial effects on aspects of the MGBA. The opposing findings regarding the
effects of cannabis on alcohol use may be partially due to the differential actions of cannabinoids throughout
the MGBA, which need to be better characterized in humans. Thus, the goal of this naturalistic study is to
explore effects of legal-market cannabis on acute and daily alcohol consumption, neurobehavioral AUD
phenotypes and MGBA function in heavy drinkers. We will recruit N=61 heavy drinking, regular users of legal-
market cannabis to complete daily diary measures of alcohol and cannabis use during two 7-day periods (a no-
cannabis period and an ad lib cannabis use period) and undergo two lab sessions; Visit A assesses cognitive
function, impulsivity, craving, alcohol self-administration, MGBA biomarkers and blood-THC levels in the
absence of acute cannabis, and Visit B tests the same outcomes following subjects’ self-administration of their
preferred legal-market cannabis in their homes. The study uses the Mobile Cannabinoid Pharmacology Lab
(an IRB-approved method developed by our team to test acute effects of legal-market cannabis and quantify
blood-THC). The PI, Dr. Karoly, will pursue training aims to broaden her skillset and enable her to develop
expertise in 1) MGBA analysis, 2) cannabinoid pharmacology, and 3) biostatistics. To guide her research and
training, Dr. Karoly has assembled a premiere mentorship team with expertise spanning these domains. She
will be well-supported as she develops the skills and expertise necessary to launch her independent, patient-
oriented, translational program of research focused on novel AUD treatment and harm reduction strategies.

Public health relevance
Project Narrative Cannabis is the most commonly used drug among people who drink alcohol, and conflicting evidence suggests that cannabinoids (the chemical constituents of the cannabis plant, including delta-9-tetrahydrocannabinol [THC]) may confer both harms and benefits on the symptoms of alcohol use disorder (AUD). Animal studies suggest the effects of cannabis among heavy drinkers may be partially due to the impact of THC on the microbiota-gut-brain axis (MGBA; which refers to the bidirectional communication between the digestive, immune, and central nervous systems), however no human studies have explicitly explored this question. This observational study will inform our understanding of the risks and potential harm-reduction benefits of cannabis among heavy drinkers by investigating the effects of THC in legal-market cannabis on acute and daily alcohol consumption, AUD symptoms, and MGBA function among heavy drinking, regular cannabis users.